DP21-001 New Jersey Pregnancy Risk Assessment Monitoring System (PRAMS) - Component A: Core Surveillance

New Jersey (NJ) PRAMS is a surveillance system designed to collect data that
contributes to the improved health of NJ mothers and infants. Information from PRAMS
is used to help plan and evaluate health programs such as those focusing on improving
early prenatal care, reducing health disparities in birth outcomes and encouraging safe
sleep practices. PRAMS provides data that can be used to inform decision making.
Project Name – New Jersey Pregnancy Risk Assessment Monitoring System (PRAMS)
– Component A: Core Surveillance
Population to be Served – New Jersey mothers and infants of all ages and in all racial
and ethnic groups with a special focus on low-income and racial/ethnic minorities.
Strategies / Interventions - The aim of the NJ PRAMS project is to use PRAMS data to
compliment other vital statistics data to respond to emerging needs of NJ mothers and
infants. PRAMS data will be essential in the evaluation of MCH programs and services,
development reports and data briefs, and dissemination of PRAMS data for informed
decision making, resource allocation and strategic planning.
Project Goals - Use PRAMS data in conjunction with other data sources to identify
subpopulation groups at risk for adverse pregnancy outcomes, identify modifiable risk
factors and promote interventions and services to prevent poor birth outcomes. Data
analysis will focus on maternal depression, racial bias, maternal morbidity, tobacco,
prenatal and preconception care, postpartum visits and disparities. NJ PRAMS will
continue to monitor safe sleep practices and breastfeeding rates as well as explore
areas such as drug use and other emerging topics and state priorities. NJ PRAMS will
expand the use of PRAMS data to improve MCH programs and services.
Measurable Objectives – Continue implementation of phase 8 survey; participate in
CDC’s revision process for the phase 9 survey; use PRAMS data to help evaluate MCH
programs and services; develop and disseminate PRAMS data briefs and reports;
update the NJ PRAMS data query on the NJ State Health Assessment Data (NJSHAD)
system; and support MCH block grant priorities and the State Maternal Health Innovation
Program.

Public health relevance
PRAMS Project Narrative New Jersey PRAMS is a surveillance system designed to collect data that contributes to the improved health of New Jersey mothers and infants. Information from PRAMS is used to help plan and evaluate health programs such as those focusing on improving access and early prenatal care, reducing smoking during pregnancy and encouraging safe sleep practices. PRAMS provides data that can be used to inform decision making.